Every Day Counts: A lifestyle program for women metastatic breast cancer

The community of women with metastatic breast cancer (MBC) is growing due to greater disease incidence
and treatment advances, with over 30% of women now surviving over 5 years (vs. just 4% in 2000). Managing
symptoms to maintain the highest quality of life (QOL) is the major goal of care in the metastatic setting. Thus,
research that addresses QOL, prognosis and survivorship in this burgeoning and underserved survivor group
is critically needed. BC treatment is associated with adverse body composition changes, specifically gains in
adipose tissue and reductions in strength and lean mass (LM). Excess adiposity contributes to inflammation
and insulin-resistance, which are theorized to promote tumor progression and loss of LM. Low levels of LM are
associated with chemotherapy toxicity, increased symptom burden and compromised survival in women with
MBC. Lifestyle interventions with early stage BC survivors result in reduced symptoms, improved biomarkers of
BC prognosis and enhanced quality of life (QOL). To date, women with MBC have been largely excluded from
these trials. Our pilot work in women with MBC demonstrates they are interested, capable, adherent and
benefit from participation in a lifestyle intervention. Our results show clinically meaningful improvements in
QOL, increased physical activity and strength. We also find improved trends in biomarkers of prognosis, as
well as mitochondrial function for women in the immediate intervention vs. control group. Further, our work
shows that inflammation-associated microRNAs are differentially expressed following participation in our pilot
trial, providing highly novel potential targets to explain mechanisms by which lifestyle interventions improve
QOL for these women. We propose a randomized atttention control trial in women with MBC (n=176) to test
the immediate and sustained effects of “Every Day Counts,” a 16-week lifestyle intervention based on current
lifestyle recommendations for cancer survivors. This trial is adequately powered to examine changes in: 1)
QOL - the primary determinant of care in the metastatic setting and (2) body composition, serum biomarkers of
prognosis/survival, and pertinent patient reported outcomes. We will also explore mitochondrial function and
novel microRNA signatures associated with inflammatory biomarkers and mitochondrial function. Every Day
Counts incorporates critical feedback and experiences from our pilot study with women with MBC. Our robust,
multidisciplinary study team applies an innovative, highly integrated physiologic model to examine the
mechanistic effects of the intervention on decidedly relevant outcomes of interest. The present study
challenges current clinical assumptions regarding the presumed ineffectiveness of lifestyle behaviors in the
metastatic setting, providing evidence that may inform a paradigm shift expanding the application and
relevance of the nutrition and physical activity guidelines to women with MBC. Importantly, this study will
provide clinicians with updated evidence and strategies to help make every day count for women with MBC
representing high impact for a currently underserved group of survivors.

Public health relevance
Narrative The community of women living with metastatic breast cancer is growing. Many are looking for programs to help support efforts to adopt healthy lifestyle behaviors that can improve quality of life and potentially enhance survivorship. This study examines the effects of “Every Day Counts,” a lifestyle intervention, on body composition, patient reported outcomes, biomarkers of inflammation and insulin resistance, adipokines; and also explores changes in mitochondrial function and miRNA.